The use of DNA-encoded library (DEL) technology for the identification of therapeutic molecules to treat opioid use disorders (OUDs)

PROJECT SUMMARY
The use of DNA-encoded library (DEL) technology for the identification of therapeutic molecules to
treat opioid use disorders (OUDs).
This Phase I SBIR project aims at the identification, using a novel DEL drug discovery platform, of small
molecular weight compounds that can bind to the receptor GPR26 belonging to the family of G-protein coupled
receptors (GPCRs) with the goal of restoring brain functions associated with the reward system without
affecting opioid receptors. Effects of opioids are mediated through GPCR μ-opioid receptors (MORs) and
indirectly through dopaminergic pathways via dopamine receptors. Some of these pathways, and the basal
ganglia signaling in general, were largely deciphered by us in the Greengard lab over the last three decades.
Morphine perturbs the mesolimbic dopaminergic system which is triggered in conditions of dependence and
withdrawal. Furthermore, morphine-dependency is associated with elevated cAMP levels, altering broad cAMP
signaling, in the striatum especially. GPCRs represent one of the most important therapeutic classes and many
of them remain largely understudied and without a known ligand (called orphan GPCRs or oGPCRs). We have
identified several oGPCRs strongly and selectively expressed in brain regions highly relevant for substance
use disorders (SUDs). Those represent a remarkable and unexploited opportunity to counteract OUDs in an
innovative way, and without targeting the opioid receptors directly. We are proposing to focus this program on
GPR26 that appears to be the strongest candidate, based on our knowledge and preliminary data, to modify
cAMP signaling and potentially rebalance the basal ganglia signaling. GPCRs drug discovery is hampered by
the need of large amounts of mostly non-physiological receptor protein (E. coli) for high-throughput screening
(HTS) and the need for a clear biological activity to perform HTS drug screening. Our research strategy is to
identify GPR26 binders addressing each of these limitations by using a DNA-encoded library (DEL) screening
approach that will allow small amounts of a physiological/high quality target to be used with very large
screening power (125 million entirely new and proprietary compounds) and a binding-based assay that is
activity-independent. The central hypothesis is that due to the very large number of compounds available to be
tested and the inherent diversity, it will be possible to identify efficiently, in a cost-effective way, compounds
that are high-affinity binders (pre-optimization) of GPR26. DEL screening protocols have been generated and
optimized focusing on minimizing the amount of protein to be used and on purifying protein targets from
mammalian cells. These steps will ensure that a physiological GPR26 version is used for screening purposes
and that screen duplicates will increase confidence and improve hits’ heuristic values determination. Aim 1 will
be dedicated to DEL screening campaigns and 125 millions of DEL compounds will be tested using purified
GPR26 or GPR26 containing membranes as target source. GPR26 will be expressed in mammalian cells,
purified, and immobilized. This will allow synthesis and validation steps proposed in Aim 2. Aim 1 will generate
a list of 100 preferred hits and we will help prioritize them for further validations. Aim 2 will include chemical
synthesis of on-DNA compounds and 18 hits off-DNA. All hits will be validated first for physical binding using
two different methods and activity will be evaluated in mammalian cells. This Program will identify and validate
compounds with 3-digit nanomolar range KD or lower and demonstrating receptor activity. This will represent a
strong proof of concept fully validating Phase I and a strong starting point to initiate Phase II with 3-5
compounds.

Public health relevance
Project narrative: Substance use disorders (SUDs) such as opioid use disorders (OUDs) result from the imbalance of signaling pathways affecting the reward system, and lead to long-lasting changes in the brain. This rewiring of the brain greatly affects G-protein coupled receptors (GPCRs), an important therapeutic class representing about a third of all FDA approved drugs. Remarkably, 85 of those receptors are understudied (also called orphan or oGPCRs), and several are highly and selectively expressed in brain regions that are important for SUDs, and selectively in important neuronal cell types. These oGPCRs represent fantastic opportunities to rebalance defective brain pathways. This Phase I SBIR proposal aims at demonstrating that our powerful DNA-encoded library (DEL) technology can be used very effectively to identify high-affinity drug- like molecules binding to one of those uncharacterized signaling receptors to modulate its activity. The goal is to correct long lasting brain signaling anomalies created by chronic opioid use and OUDs in general without targeting the problematic opioid receptor system, or any of the conventional ones including the dopaminergic system. Demonstrating the validity of this approach could serve as the blueprint for finding cures to other SUDs.